Social connectedness in the transition to parenthood: Implications for parent and child health and well-being

Project Summary
One of the most important methods of promoting children’s positive adaptive skills is improving caregiver well-
being6,7. Postpartum mood disorders affect up to 40% of new parents8-10, and confer significant risk to child
development8,11. Additionally, the transition to parenthood triggers changes to social life, which may lead new
parents—both mothers and fathers—to feel lonely and less socially connected3, which may exacerbate declines
in parents’ mental health4,5. Social connectedness—the extent to which people feel close and connected to other
people—is linked with improved mental and physical health across the lifespan12-14. Further, social
connectedness is only moderately correlated with other relationship processes, such as social network size,
relationship satisfaction, and social support15, suggesting that it may confer unique protective benefits. However,
remarkably few studies have systematically investigated changes in social connectedness during the transition
to parenthood and their implications for postpartum mental health and child development. Given the unique
neurobiological, psychosocial, and behavioral changes that occur during the transition to parenthood16, research
on social connectedness during the perinatal period and its connection to child development is needed. We
propose to fill this critical knowledge gap in this R21 investigation. Specifically, we will examine social
connectedness among first-time expectant mothers and fathers and their associations with health and well-being
outcomes from pregnancy to 4-months postpartum. We will incorporate comprehensive measures of social
connectedness (loneliness, connectedness), distress (depressive, anxiety, and birth-related PTSD symptoms),
well-being (positive and negative emotion, life satisfaction), child development (delivery outcomes, Bayley
Scales, temperament), and caregiving outcomes (parental sensitivity, parental bonding, parental reflective
functioning). We propose that changes in social connectedness will be associated with parents’ postpartum
distress and well-being, as well as child development and caregiving outcomes independent of other social
processes. Furthermore, we propose that parents’ mental health will be one psychosocial mechanism linking
social connectedness to child outcomes. The findings from this research will be important as they will
demonstrate for the first time the unique transgenerational impact of mothers’ and fathers’ social connectedness,
transforming understanding across multiple areas of research, including research on postpartum mental health,
fatherhood, child development, and close relationships. Moreover, the successful completion of this research
will establish an empirical foundation for additional investigations on biopsychosocial mechanisms linking social
connectedness to health and well-being during the perinatal period, which will inform new intervention
approaches targeting broader social connectedness. Given the importance of parent mental health for child
development, improving parents’ experiences promises to benefit the entire family.

Public health relevance
Project Narrative The transition to parenthood—a time rife with stress and adjustment—triggers changes to social life, which may lead parents to feel lonely and less socially connected1-3, potentially heightening their risk for declines in mental and physical health4,5; however, remarkably few studies have examined the consequences of social connectedness during the transition to parenthood for parents and their developing infants. We propose that changes in social connectedness—the extent to which people feel close and connected to people in their lives— during the transition to parenthood will be critically linked to parent and child health and well-being. The current study will be the first to examine changes in social connectedness during the transition to parenthood and their associations with mothers’ and fathers’ postpartum distress and child health and well-being, thus laying a critical foundation for interventions that target social connectedness to optimize the health and well-being of parents and children during the perinatal period and beyond.